Proprioceptive Detection of Joint Limits and Its Role in Limb Sensorimotor Control

Project Summary
Many animals have specialized proprioceptors that fire when a limb reaches the limit of its range. In
mammals, including humans, the extremes of joint position are detected by low-threshold Ruffini
endings and Pacinian corpuscles embedded within joint capsules. Like other proprioceptors, joint
receptors are distributed throughout the body, which has made it challenging to understand if and how
they are specialized for sensing and controlling specific movements. This project will leverage tools only
available in the fruit fly, Drosophila, to provide new insight into basic neural mechanisms of limb
sensorimotor control by specialized proprioceptive organs called hair plates. Hair plates are tightly-
packed arrays of sensory hairs positioned close to joints in the insect cuticle. Our preliminary data
suggests that hair plate proprioceptors fire at the limits of the joint range, in a manner analogous to
mammalian joint receptors. In this project, we will combine experimental and computational
approaches to test the hypothesis that hair plates function as proprioceptive limit detectors to stabilize
limb posture and guide movement. A deeper understanding of proprioceptive limit detection and its
contributions to motor control has the potential to transform the way in which we understand and treat
sensorimotor disorders.

Public health relevance
Project Narrative This collaborative project applies innovative methods to understand how proprioceptive sensors detect the limits of limb joint movement, and how downstream neural circuits use these signals to refine motor control.